High Framerate Plane-Wave Variance of Acceleration and Vector Flow Imaging for the Characterization of Atherosclerotic Plaque Morphology and Assessment of Vascular Hemodynamics

PROJECT SUMMARY
The need for minimally invasive methods for screening early predictors of ischemic stroke are required to
combat the increase in cardiovascular disease cases while reducing number of unnecessary carotid
endarterectomies, which are invasive but preventative procedures to remove plaques. The current gold-standard
for diagnosis, duplex ultrasound, is often used to detect heavily occluded vasculature, but simply noting the
degree of stenosis is an insufficient measure of plaque rupture vulnerability. Acoustic Radiation Force Impulse
(ARFI) ultrasound technique recently emerged as a potential method to separate vulnerable from stable plaques
through delineation of plaque components. However, as the technique relies on emission of high intensity
focused acoustic pulses, although nondestructive, the potential for tissue heating limits extended uses, while the
long period of data collection increases opportunities for motion artifacts to corrupt data collection and
physiological interpretation of results. The use of a new ultrafast ARFI imaging sequence to evaluate both
plaque structure and surrounding hemodynamics may provide significant advancement in reducing
acquisition time, reducing acoustic heating, and improving risk prediction. There exists overwhelming
evidence that mechanics of plaque growth and rupture are governed by shear forces acting on the vessel walls.
Monitoring the dynamics changes in shear stress in addition to more efficiently detecting plaque composition
may prove a novel avenue for discerning at risk patients with vulnerable atherosclerotic plaques vs those with
stable plaque phenotypes. We propose to further develop and characterize ultrasound parallel transmit
sequences to image tissue in rapid succession and additionally detect multi directional blood flow around the
vasculature. Combining the ARFI elastography, high framerate imaging, and flow information allows a real-time
realizable assessment of the plaque environment throughout the entire cardiac cycle. Therefore, meeting the
aims of the study will further develop diagnostic imaging tools for future stroke risk assessment.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The risk for ischemic stroke, one of the leading causes of death in the world, is currently determined through the use of duplex ultrasound, from which physicians obtain the amount of stenosis. This metric taken by itself is misleading, as it does not represent the true vulnerability of an atherosclerotic plaque, better predicted by morphology and hemodynamic forces at play. In order to better assess when surgical intervention is actually necessary to prevent strokes, we propose a safe, efficient, and more holistic approach to preemptive screening that combines delineation of plaque structure and composition with flow and wall shear stress through a novel plane wave variance-of-acceleration and 2-D vector flow ultrasound imaging approach.